Molecular mechanisms of age-related lymphatic dysfunction

PROJECT SUMMARY/ABSTRACT
Aging results in impaired lymphatic function in a variety of organ systems. This is important because
the lymphatic system has many physiologic functions, and lymphatic abnormalities are implicated in many
pathologic conditions that affect the elderly. However, while it is clear that aging impairs lymphatic function, the
cellular mechanisms that regulate this response remain largely unknown. In addition, the effects of aging on
lymphatic endothelial cell (LEC) response to vascular endothelial growth factor C (VEGFC), downstream
pathways involving Pi3k and Akt signaling, and interactions with lymphatic muscle cells have not been
analyzed.
In previous and preliminary studies, we have found that chronic inflammation in a variety of settings,
including obesity, lymphedema, and aging, results in decreased intracellular LEC Pi3K/Akt signaling. This is
important since LEC Pi3K/Akt signaling is a key regulator of LEC proliferation, differentiation, and function.
These findings are consistent with previous studies demonstrating that abnormalities in Pi3k/Akt signaling also
contribute to age-related blood endothelial dysfunction. In this proposal, we aim to test the hypothesis that
decreased LEC intracellular Pi3k/Akt signaling plays a causal role in age-related lymphatic dysfunction.
Our study is innovative because previous studies have been largely observational and have not
analyzed lymphangiogenic signaling in aging. We have also developed novel transgenic mice that enable us to
selectively analyze the effects of changes in LEC intracellular Pi3k/Akt signaling, thus avoiding the limitations
of previous studies that have relied on the systemic administration of recombinant VEGFC or VEGF-R3
antibodies. Using two aims, we will determine how aging changes LEC Pi3k/Akt signaling in different tissues
and how these changes correlate with lymphatic function. These studies will help us determine how LECs
respond to VEGFC in aging and how these changes modulate response to inflammation and nitrosative stress.
In other studies, we will determine if inhibition of intracellular LEC Pi3k/Akt signaling in young mice can
recapitulate the lymphatic phenotype of old mice. Finally, we will determine if increased LEC Pi3k/Akt signaling
can improve lymphatic function in elderly mice.
At the conclusion of our proposed research, we will have a detailed understanding of the cellular
mechanisms that contribute to age-related lymphatic dysfunction. This understanding will provide the basis for
future studies designed to improve lymphatic function.

Public health relevance
PROJECT NARRATIVE Aging results in impaired lymphatic function in a variety of organ systems and may contribute to pathologic conditions that affect the elderly. Impaired responsiveness to VEGFC and decreased intracellular Pi3k/Akt signaling may provide a rationale for the structural and functional changes that occur in aging lymphatics. Modulation of these pathways may therefore represent a novel means of improving lymphatic function in the elderly.